Transcriptional regulation of Myelopoiesis

Abstract
Myeloid cells are amongst the first responders to pathogenic insults, but there remains a substantial knowledge
gap concerning mechanisms that control their development in the bone marrow (BM). We have found that the
transcription factor ThPOK (T-helper-inducing POZ-Kruppel factor) plays a critical unexpected role in myeloid
lineage differentiation, as ThPOK null mice show expansion of neutrophil progenitors and precursors in the BM,
leading to neutrophilia and protection against sepsis. Loss of ThPOK expression causes widespread
transcriptional reprogramming throughout myelopoiesis. Here, we propose to test the hypothesis that ThPOK
serves as a transcriptional checkpoint for neutrophil commitment and granulocyte lineage output in 3
specific aims. Aim 1 will define how growth factor (GF)/cytokine receptor signaling regulates ThPOK
expression in myeloid progenitors. The upstream factors that control ThPOK induction during myelopoiesis
are not known but are likely to include BM-derived GF / cytokine(s), which are known to direct myeloid lineage
choice. Here we will define the signaling cascade/s from GF/cytokine receptor to ThPOK transcriptional cis
element that control ThPOK induction at each specification step. We will use in vitro hematopoietic progenitor
cultures, an existing panel of knock-in mouse models harboring mutations in the ThPOK cis elements to delineate
the upstream pathways that drive ThPOK expression during myelopoiesis. Aim 2 will elucidate the modus
operandi by which ThPOK regulates gene expression during myelopoiesis. The mechanism by which
ThPOK regulates myelopoiesis remain largely unclear. We propose that ThPOK acts in part by recruiting co-
factors to modulate chromatin accessibility, including the NuRD complex. We have generated 3 different ThPOK
and 2 GFI1 mutant mouse models that alter their ability to interact with cofactors or with DNA binding sites. Using
myeloid and granulocyte progenitors from these mutant mice, chromatin accessibility assay, ChIP seq, and
RNAseq we will determine the functional outcomes of ThPOK and GFI1 interaction on myelopoiesis. Aim 3 will
test the hypothesis that ThPOK is a critical regulator of infection-induced emergency myelopoiesis.
Emergency myelopoiesis is critical for enhanced release of neutrophils and monocytes from the BM during
infection, but the underlying regulation remains poorly understood. Our preliminary data suggest a role for
ThPOK. Using our established ThPOK loss- and gain-of-function mouse models, we will examine the functional
consequences of ThPOK-mediated gene regulation on LPS and GCSF-mediated emergency myelopoiesis. This
proposal represents the first study to dissect the role of ThPOK in myeloid development and function, and if
successful will represent an important advance in the field. The proposed studies will ultimately allow
development of novel treatment strategies to reprogram myelopoiesis under different pathological conditions
such as neutropenia, sepsis, and Myeloproliferative Disorder through targeting of ThPOK and its associated
pathways.

Public health relevance
Project Narrative Based on strong preliminary data we propose that the transcription factor ThPOK serves as a critical transcriptional checkpoint for neutrophil commitment in granulocyte lineage-specified cells and thereby enforces a set point for granulocyte lineage output. Here we will dissect the upstream pathways that control ThPOK induction during myelopoiesis, the modus operandi by which ThPOK controls transcription, and its importance for emergency myelopoiesis. Completion of these studies will provide critical insights into the contribution of ThPOK to homeostatic and emergency myelopoiesis and provide a conceptual basis for the future design of therapeutic strategies for the treatment of neutropenia, sepsis, and Myeloproliferative Disorder through targeting of ThPOK and its associated pathways.